Cancer Center Administrative Core

Project Summary - Cancer Center Administration
The DLDCCC’s overarching role is to coordinate cancer-relevant research, education, patient care, and
community outreach activities, and to address the cancer-related health issues of the residents in our
Catchment Area (CA). Cancer Center Administration is organized and staffed to provide operational and
financial support to Senior Leadership, the general membership, and manage the mission critical activities of
the DLDCCC in a complex matrix organizational environment. The Administrative Core plays a major role in
facilitating the creation and implementation of the DLDCCC Strategic Plan, managing evaluation and planning
and the activities of our external and internal committees, monitoring progress, and ensuring that researchers
have the resources needed to enable optimal research both within the Center and across the BCM and partner
institution matrix. Administration continues to improve on previously created or introduced tools, databases,
and standardized processes and works closely with their departmental and central administrative colleagues in
the College to achieve our goals.